Project 1 - HEARTSPOT: Evaluating a Machine Learning System to Aid Decision-Making in the Emergency Department for Patients with ADRD

OTHER PROJECT INFORMATION – Project Summary/Abstract
Project 1: HEARTSPOT: Evaluating a Machine Learning System to Aid Decision-Making in the
Emergency Department for Patients with ADRD
The HEARTSPOT project seeks to improve accuracy in the treatment of acute coronary syndrome (ACS) for
patients with Alzheimer’s disease and related dementias (ADRD). An augmented intelligence algorithm will be
deployed across a large health system’s electronic medical record through a randomized evaluation to learn
about ACS, detect risk signals for individual patients, and generate a new decision aid for emergency department
clinicians. The goal is to give clinicians as much synthesized information on patient risk as possible at the point
of deciding on the ACS treatment path. This project may improve ACS decisions for patients overall, for elderly
patients given the complexity of their care decisions, but in particular for ADRD patients, for whom the algorithm
may help fill critical information gaps necessary for clinicians to accurately assess ACS risk. While focused on
improving healthcare decision-making in emergency departments and relating to ACS treatment for patients with
ADRD specifically, Project 1 complements the work of the other four projects that all study different influences
on healthcare for ADRD patients and healthcare disparities in different settings and contexts.

Public health relevance
OTHER PROJECT INFORMATION – Project Narrative An emergency department clinician treating a patient with acute coronary syndrome (ACS) faces difficult decisions about whether to recommend invasive treatment. If the patient is cognitively impaired, assessing health risks and benefits is even more complex. This project will test a machine learning tool called HEARTSPOT that presents a report to help clinicians make this difficult decision. HEARTSPOT will examine each patient’s medical history faster and more completely than any human could and present a summary of its findings to the emergency department clinician in real time.